DATA COLLECTION SERVICES FROM THE COLORADO CENTRAL CANCER REGISTRY IN SUPPORT OF THE PILOT OF PATTERNS OF CARE STUDIES.

PROCUREMENT OF DATA COLLECTION SERVICES FROM THE COLORADO CENTRAL CANCER REGISTRY IN SUPPORT OF THE PILOT OF PATTERNS OF CARE STUDIES